TRIAL OF OXCARBAZEPINE IN PATIENTS WITH PARTIAL SEIZURES

This protocl assesses the safety and efficacy of oxcarbazepine monotherapy in epilepsy patients with partial seizures whose seizures have been difficult to control with currently available medications.